Novel Biocompatible, High-Throughput Cryopreservation Medium and Method for Enhanced Post-Thaw Migration and Cytotoxicity of NK Cells

SUMMARY
Recent breakthroughs in CAR-T cell therapies have revolutionized immunotherapy, sparking growing interest in
NK cell-based treatments due to their lower risk of graft-versus-host disease and ability to target tumors
independently of MHC class I expression. However, current cryopreservation methods using toxic, cell-
permeating agents significantly impair NK cell migration, cytotoxicity, and cytokine production, limiting their
therapeutic efficacy and scalability for clinical applications.
CryoCrate, an NIH Innovation Showcase Company, is developing OdinSol®, a novel polysaccharide-based
cryopreservation medium specifically designed to enhance the post-thaw viability and functionality of NK cells
without the use of permeating cryoprotectants. OdinSol® leverages nanoscale cubic ice formation and molecular
assembly technologies to preserve NK cell migration, cytotoxicity, and cytokine production. This project aims to
achieve three milestones:
1. Optimize OdinSol® for primary NK cells, ensuring high post-thaw viability, enhanced cytotoxicity, and
validated tumor-killing efficiency in vitro.
2. Produce a GMP-compliant prototype batch with verified stability and quality control, ensuring the
scalability of OdinSol® production.
3. Validate the in vivo safety and efficacy of GMP-grade OdinSol® in immunotherapy applications by using
a standard animal model, and secure FDA clearance for clinical use.
The success of this project will significantly improve the manufacturing and clinical application of NK cell
therapies, making them more scalable, effective, and accessible for cancer treatment.

Public health relevance
NARRATIVE Conventional cryopreservation methods significantly impair the post-thaw migration and cytotoxicity of NK cells, reducing their effectiveness in immunotherapies. This project aims to develop and optimize OdinSol®, a novel biocompatible cryopreservation medium that eliminates the need for permeating cryoprotectants and addresses the limitations of traditional methods.